Influence of nutritional status on the neurochemical bases of habit

PROJECT SUMMARY / ABSTRACT … ………………………..
Early success with weight loss is too often followed by weight regain. One factor contributing to weight regain is
the re-emergence of old eating habits after exposure to familiar food cues. Striatal dopamine drives habits, but
the inhibitory neurotransmitter GABA can regulate dopamine and affect habit as well. Initial evidence suggests
that factors related to nutritional status, for example body mass (BMI) and diet composition, may be associated
with this neurochemistry. To facilitate improving long term dietary adherence and weight management, it is
critical to determine what influence one’s weight and diet might have on dopaminergic and GABAergic function
and thus susceptibility to habit-driven eating. The long-term goal of the candidate, Dr. Darcey, is to establish an
independent research career identifying and developing nutritional approaches which impact neurochemistry to
affect the strength of habit-driven vs. goal-directed behavior. The overall objective for this K99/R00 application
is to determine how BMI and diet composition influence the neurochemistry of habit-driven eating behavior. In
the K99 phase, to isolate the relationship between body weight and habit neurochemistry, Dr. Darcey will lead a
cross-sectional inpatient study under standardized dietary conditions to determine the relationship between
striatal GABAergic tone, dopamine D2 receptor availability, and adiposity in adults across a wide range in BMI
(n=50). In the R00 phase, to isolate the causal role of diet on habit neurochemistry, Dr. Darcey will lead a
randomized cross-over outpatient, controlled feeding study to determine the effect of dietary fat versus
carbohydrate restriction on GABAergic tone, DA function, and habit-driven behavior in only adults with obesity
(n=72). This proposal also includes training designed to aid Dr. Darcey’s transition from a mentored postdoctoral
fellowship to an independent tenure-track assistant professorship at a research-intensive institution studying the
interaction between diet and the neurochemistry of behavioral control using multi-modal neuroimaging. Dr.
Darcey will continue to expand her existing knowledge base and skills in PET and fMRI neuroimaging and data
analysis. Through this award she will gain new skills in rigorous clinical trial design and Magnetic Resonance
Spectroscopy (MRS), a noninvasive neuroimaging technique to probe neurochemistry. Dr. Darcey’s mentoring
team includes leading experts in diet/metabolism and body weight regulation (Dr. Kevin Hall), dopamine receptor
PET imaging and alcohol/substance use disorders (Dr. Gene-Jack Wang), and GABA MRS in psychiatric
disease (Dr. Graeme Mason). The NIDDK Intramural Research Program provides an ideal environment to
accomplish this proposal, from the participant recruitment resources, inpatient use of the Metabolic Research
Unit and precisely prepared study meals in the Metabolic Kitchen, to dopamine D2 receptor PET imaging and
the MRS Core. Successful completion of the proposed studies and career development activities will position
Dr. Darcey for success in attaining a faculty position, establishing her independent research program, and
competing for future NIH support for research to advance the neuroscientific understanding of dietary adherence.

Public health relevance
PROJECT NARRATIVE… . Adhering to a diet in the long term to maintain a reduced body weight is challenging, particularly as familiar food cues prompt old dietary habits to re-emerge. The knowledge gained from the proposed studies will advance our understanding of the role that both body weight and diet composition have in the function of the neurochemical systems underlying habit-driven eating behavior. This information may help to identify neuroscience-informed nutritional strategies to improve long-term adherence to weight management programs.